Admin Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The RCMAR Center for Aging in Diverse Communities (CADC) at the University of California San Francisco
(UCSF) has been funded continuously since 1997. We have well-established comprehensive, interdisciplinary
program of research and mentoring with broad impact on minority aging research. CADC's research theme
focuses on understanding mechanisms of health disparities and developing interventions to improve those
disparities. CADC's assets include strong minority and scientific leadership and a passionate commitment to
achieving health equity among older adults. CADC is a magnet center at UCSF for faculty and post-doctoral
fellows conducting health disparities research. Located in the San Francisco Bay Area, CADC has
geographical access to every major racial/ethnic group in the U.S. and a range of economically diverse and
sexual and gender minority populations of older adults. We have relationships and studies in urban and rural
communities, and an extensive network of over 100 community and health care partners serving older adult
disparity populations, which we utilize to enrich the research opportunities and mentoring of our CADC
Scientists (underrepresented minority aging and health disparities investigators). For the next 5 years, our
CADC Administrative Core (AC) will continue to provide intellectual leadership and manage our robust
mentoring program for underrepresented investigators focused on our research theme. The aims of the AC
are to 1) coordinate the activities of our Research Education Component (REC), Analysis Core (AnC), and
Community Liaison and Recruitment Core (CLRC) internally, and externally with other RCMARs and the
RCMAR Coordinating Center; 2) conduct a rigorous recruitment, review and selection process to award 3-4
pilot study grants per year to CADC Scientists focused on the Center's research theme; 3) maintain a system
for tracking pilot study investigators through award of independent research funding (e.g., NIH R01 or K award)
and complete a semi-annual report with the RCMAR Coordinating Center; 4) with guidance from an internal
Executive Committee composed of all CADC Faculty, an External Advisory Committee (composed of minority
aging scientific experts Lisa Barnes, PhD, Lisa Cooper, MD, and Kenneth Covinsky, MD), and a Community
Advisory Board, the AC will maintain the structure, processes, and culture of the CADC to effectively mentor
CADC Scientists; 5) ensure the participation of at least three CADC Faculty and two CADC Scientist
representatives at the annual RCMAR meetings; and 6) expand joint research and mentoring activities
between CADC Faculty and Scientists and other NIA-sponsored Centers, programs, and aging-related
researchers, e.g., the UCSF Memory and Aging Center (NIA-funded Alzheimer's Disease Research Center)
and the UCSF Pepper Center. The AC will ensure integration of our cores to provide a robust, mentoring
program for underrepresented junior investigators who will enhance the diversity of the aging-related workforce
and help meet the needs of our aging and increasingly diverse older adult population for years to come.